PHASE I/II PROTOCOL TO EVALUATE ELECTROINSERTED RBC-RCD4 IN HIV SUBJECTS

This study is to evaluate the safety, tolerance, and antiretroviral activity of rCD4-RBCs from a donated blood volume of up to 400 ml administered as a single infusiton to HIV-infected volunteers. Patient recruitment is complete.